Quantitative Data Sciences Core Facility Shared Resource

ABSTRACT – QUANTITATIVE DATA SCIENCES CORE
The Quantitative Data Sciences Core (QDSC) provides a state-of-the-art integrated approach for Data Science
support to Lurie Cancer Center (LCC) members in the basic, clinical and population sciences. ‘Data Sciences’
includes the three disciplines of Biostatistics, Bioinformatics and Clinical Informatics. Since the last CCSG
review, the former Biostatistics Core and Cancer Informatics Core have been integrated into a new QDSC to
provide a unified approach to data definition, acquisition, management, analysis and reporting. The QDSC
Director is Alfred Rademaker PhD; Associate Directors are Denise Scholtens PhD (Biostatistics), Matthew
Schipma PhD (Bioinformatics) and Firas Wehbe MD,PhD (Clinical Informatics). As part of this consolidation, the
core has been expanded through the addition of faculty and staff effort bridging the fields of informatics and
statistics, areas of expertise often sought together by members of the LCC. The QDSC also works collaboratively
with the Pathology Core Facility, the Outcomes Measurement and Survey Core, and the LCC Clinical Trials
Office.
The Biostatistics component provides power calculations and statistical analyses to investigators who are
planning and conducting basic and preclinical studies and assists in the development of early phase and
randomized clinical trials. The Bioinformatics component provides support for the analysis of next generation
sequencing data, pathway identification, variant detection, methylation analysis, and data visualization. The
Clinical Informatics component provides clinical trial management, disease-based database and informatics
tools, project specific Research Electronic Data Capture (REDCap) development, pathology data management,
and support for accessing and analyzing Northwestern Medicine Electronic Data Warehouse (NMEDW) data.
QDSC Clinical Informatics has integrated and augmented the Northwestern Oncology Trial Information System
(NOTIS), LCC’s clinical trial management system, and the electronic medical record (Epic) used by our clinical
partners.
QDSC has been heavily used by cancer researchers, with 109 LCC members using the Core in the last year,
and it has been instrumental in the publication of 151 papers, many in high impact journals. Moreover, it has
contributed to the success of many grant applications, notable among them a renewal of a SPORE in Prostate
Cancer and a new U54 Chicago Collaborative to Promote and Advance Cancer Health Equity.